A novel role of cholesterol and SR-BI in adipocyte biology

Project Summary (30 lines of text)
Adipocytes play a key role in energy homeostasis, storing energy in the form of triglyceride (TG). In addition to
neutral lipids, adipocytes contain abundant free cholesterol derived from circulating HDL cholesterol. There is a
strong positive correlation between adipocyte cholesterol content and TG content, suggesting mechanistic
linkage between adipocyte cholesterol and TG regulation. However, how adipocyte cholesterol is modulated by
HDL cholesterol, and if and how cholesterol homeostasis in adipocytes influences TG accumulation are
unknown. Scavenger receptor class B type I (SR-BI, encoded by SCARB1) is a high-affinity HDL receptor that
is abundant in adipocytes. We recently discovered that mice selectively deficient in SR-BI in adipocytes (SR-
BI∆AD) are protected from high fat diet-induced adiposity, their adipocytes are smaller, and they have decreased
white adipose tissue (WAT) HDL cholesterol uptake and cellular cholesterol content. The overall goal of the
project is to elucidate how HDL cholesterol and SR-BI influence adipocyte TG content, and to determine if
adipocyte SR-BI expression is genetically regulated in humans to potentially impact the risk of obesity. Three
Aims will be pursued in novel mouse models and cultured human adipocytes. Aim 1 will determine if HDL
cholesterol and SR-BI promote adipocyte TG accumulation through transcriptional regulation of genes that
control lipid homeostasis. We have determined that in SR-BI∆AD WAT the expression of liver X receptor β (LXRβ)
and its target genes is downregulated and the content of oxysterols, which are LXR ligands, is decreased. Aim
1 will test the hypothesis that via HDL cholesterol uptake, adipocyte SR-BI promotes TG accumulation by
providing the substrate for Cyp27a1 which converts cholesterol to oxysterols, leading to upregulation of LXRβ
and its target genes. Aim 2 will determine if HDL cholesterol and SR-BI promote adipocyte TG accumulation by
supporting adipocyte free fatty acid (FFA) uptake, which occurs in caveolae, which are cholesterol-rich plasma
membrane domains. By electron microscopy we have discovered that caveolae content is markedly decreased
in SR-BIAD adipocytes. Aim 2 will test the hypothesis that SR-BI-mediated HDL cholesterol uptake promotes
FFA uptake and subsequent TG accumulation by supporting caveolae formation and maintenance. Aim 3 will
determine how adipocyte SR-BI expression is transcriptionally regulated in humans, and if there is a genetic
predisposition to obesity related to adipocyte SR-BI expression. Using a novel deep learning algorithm, we have
identified a potential distal enhancer for SCARB1 within a region on Chr 12 harboring SNPs highly associated
with obesity. In cultured human adipocytes, CRISPR/Cas9 deletion of the candidate region decreases SR-BI
expression. Using further mutagenesis and interrogation of transcription factor binding sites, we will test the
hypothesis that there is a remote enhancer of SCARB1 that harbors SNPs that influence the risk of obesity by
their impact on adipocyte SR-BI expression. Collectively the proposed studies will reveal fundamental processes
by which HDL cholesterol and SR-BI govern adipocyte function and thereby impact the development of obesity.

Public health relevance
Project Narrative The aim of the proposed research project is to determine how the HDL receptor SR-BI in adipocytes regulates the process by which high-fat diet feeding induces lipid accumulation in adipose tissue. We anticipate that the new knowledge gained will deepen our understanding of adipocyte biology through investigation of a novel, previously unappreciated role of HDL- cholesterol and its receptor SR-BI. Considering the staggering impact of obesity on metabolic and cardiovascular diseases, the goal of the research project is in line with the objectives of the National Institute of Health to address these disorders through medical research.